Macropinocytosis and Pulmonary Fibrosis

PROJECT SUMMARY/ABSTRACT
This R01 proposal describes a five-year research plan that will facilitate a research program dedicated to
determining the roles of macropinocytosis and its molecular mechanisms in pulmonary fibrosis. Idiopathic
Pulmonary Fibrosis (IPF) is a chronic, progressive, fibroproliferative interstitial lung disease whose etiology
remains unknown. Little is known about the molecular mechanisms involved in the pathogenesis of IPF. This
project will focus on elucidating the key roles of macropinocytosis in lung fibrogenesis, as well as their therapeutic
applications. Macropinocytosis is an actin-dependent but clathrin-independent endocytic process that mediates
the nonselective internalization of extracellular contents, such as proteins and free amino acids (AA).
Macropinocytosis is one of the major routes of nutrient uptake from the extracellular environment for various
cells and is known to be involved in cell survival, migration, and metabolism. However, the role of this process
in lung fibrogenesis is currently unknown. Our preliminary findings suggest that the inhibition of macropinocytosis
attenuates myofibroblast differentiation and lung fibrosis in mice.
Here, we will determine whether macropinocytosis exerts profibrotic responses in lung fibroblasts and
experimental pulmonary fibrosis. Further, we will also identify the molecular mechanisms by which
macropinocytosis regulates profibrotic responses in activated lung fibroblasts. We will test our
hypotheses by addressing the following Specific Aims: In Aim 1, we will assess whether macropinocytosis
deficiency attenuates fibrosis in repetitive and aged models of pulmonary fibrosis, primary cell culture system
and precision cut lung slices. In Aim 2, we will determine the effect of macropinocytosis-mediated amino acid
uptake on the expression of profibrotic genes in activated lung fibroblasts. In Aim 3, we will assess the potential
anti-fibrotic effect of macropinocytosis inhibitors in pulmonary fibrosis.

Public health relevance
PROJECT NARRATIVE Idiopathic Pulmonary Fibrosis (IPF) is the most common cause of pulmonary fibrosis worldwide. IPF is a chronic, progressive, and lethal lung disease affecting approximately 200,000 patients in the US and more than 5 million people worldwide with steadily increasing incidence and mortality. This project will determine the key roles of macropinocytosis and its mechanism(s) in the pathogenesis of pulmonary fibrosis, using a combination of in vitro, in vivo and ex vivo experimental approaches.